Human Organ of Corti Micromechanics

There has been significant effort on measurements and modeling to decipher organ of Corti (OoC) micro-
mechanics in laboratory animals. A parallel effort has been lacking for the human cochlea, but is now possible
thanks to new motion measurements and imaging in fresh human temporal bones. Notable differences between
human and animal cochlear partitions have been observed. These findings point to the need to study cochlear
micro-mechanics in humans directly. The goal of the proposed project is to understand in human cochleae (1)
the forward transduction that drives inner hair cell (IHC) and outer hair cell (OHC) stereocilia and (2) the reverse
transduction that amplifies OoC motion via OHC electromotility. A novel finite element (FE) technique will be
used to model thin slices of the cochlea, which makes it computationally feasible to incorporate anatomically
accurate OoC cytoarchitecture and the details of surrounding structures. The high accuracy of the technique in
capturing 3D motions was shown in recent publications. Slice FE models of the human basal high-frequency
(1st) and middle frequency (2nd) turns will be built with detailed anatomy and material properties determined using
OCT vibrometry data from locations along the human cochlear partition (Specific Aim 1). Each anatomical detail
can lead to unknown mechanics that will be explored through specific hypotheses. We hypothesize (H1) that,
due to the mobile bridge of the human cochlea, OHC stereocilia move in the inhibitory direction with BM upwards
motion, which is opposite to that of the classical model derived for laboratory animals. We further hypothesize
(H2) that IHC stereocilia are mainly driven by fluid flow in and out of the inner spiral sulcus due to sub-tectorial
space height change, while OHC stereocilia are mainly driven by TM-RL shear motion, and that the exact
combination of the two mechanisms for each type of hair cell will change with frequency. The different
combinations of mechanisms will provide different gains and phases of stereocilia motion relative to BM
transverse motion at different frequencies. We hypothesize (H3) that TM material properties and size will have
an influence on the radial vibration modes of the TM, affecting both stereocilia gain and phase. The phase of
OHC stereocilia motion is crucial in active feedback mechanism, while the gain of IHC stereocilia will directly
affect the sensitivity and tuning of sound perception. Our hypotheses will be tested (Specific Aim 2) by observing
the IHC and OHC stereocilia deflection angles in relation to TM-RL shear and sub-tectorial space height change,
and their frequency dependency. The roles of the mobile OSL and bridge, and the TM size and material
properties on IHC and OHC stereocilia drives will be tested by model parameter variations. Last, “reverse
transduction” will be studied by simulating electrically-evoked responses of the OoC (Specific Aim 3) using the
same model developed for the passive cochlea. Preliminary work towards a fully active slice model will also be
done. OoC micro-mechanics is a crucial part of the puzzle for understanding the extraordinary tuning of human
hearing. The proposed project will be the first to model passive and active OoC micro-mechanics in humans.

Public health relevance
Project Narrative The proposed research will help to address the needs of the millions of people with sensorineural hearing loss, by providing a better understanding of how the microscopic cellular and acellular structures of the cochlear partition work together to produce the sensation of hearing. By modeling the micro-mechanics of the cochlea in humans using a novel Finite Element slice modeling technique with anatomically accurate cytoarchitecture of the organ of Corti and its surrounding structures, we will be able to understand the forward and reverse transduction pathways directly affecting sensitivity and tuning in human hearing, and the roles of human- specific and non-specific structures in these pathways, which will allow us to predict how a patient’s hearing would be affected by specific types of structural damage or genetic mutations, thus providing a powerful way of diagnosing hearing problems in terms of their structural basis. These models may also accelerate the development of hearing aids compensation strategies such as cochlear implants, by providing ways of predicting and comparing the hearing outcomes of those strategies, and by providing understanding of the structural changes in the cochlea arising from different forms of hearing damage.